A Training and Fidelity Model to Move and Scale Evidence-based Dementia Care and Caregiver Support Programs into Practice: The Case for COPE in PACE service settings

This NIA Stage I study is designed to address two leading barriers to implementation of
evidence-based dementia care and caregiver support programs into long-term care settings: (1)
lack of streamlined, user-friendly, and tested training modalities, and (2) lack of scalable,
practical processes to accurately measure fidelity in “real world” settings. The aims of the study
are to determine whether an online training program is the same or better in improving
interventionist fidelity to an evidence based dementia program (COPE) and dementia patient
outcomes when compared to a high intensity face-to-face traditional form of training. To
accomplish these aims we will develop an online, principle-driven approach using state-of-the-
science simulation and best practices and a scalable approach to assess fidelity to COPE by
applying computational linguistics techniques. We will then conduct a noninferiority trial in
Programs for All Inclusive Care for Elders (PACE) organizations randomly assigned to the
training conditions. PACE staff will be evaluated post training on their fidelity outcomes. Dyads
of persons with dementia and their caregivers will be evaluated at 4 months post COPE
implementation on function, neuropsychiatric symptoms, quality of life, and caregiver burden.
The findings from this project will lay the essential groundwork for a large scale, Stage III-IV,
pragmatic trial of COPE in PACE settings throughout the US. Findings will also serve as a
model for guiding the development of practical, scalable processes for training and fidelity
monitoring in other long-term care settings and for other evidence-based support programs.

Public health relevance
Most persons with dementia and their caregivers do not have access to or receive beneficial and supportive evidence-based programs due to the need for scalable and reliable training and monitoring procedures for clinicians. We address this gap to developing and testing a replicable, accessible, and sustainable processes for training and monitoring clinicians in Care of Persons in the Environments (COPE) - an evidence based dementia care program - in a long-term care service setting. Study findings will yield an understanding of ways to move evidence into real-world dementia care settings and can serve as a model for guiding the development of practical, scalable processes for training and fidelity monitoring in other long-term care settings and for other evidence-based support programs.